Racial Disparities in Uterine Fibroid Care Pathways

Compared with White women, Black women are 3 times more likely to develop fibroids and experience more
significant symptoms, have higher hospitalization rates, and are more likely to schedule a uterine-sparing
treatment. Although uterine-preserving treatment approaches can often effectively manage symptoms during the
early disease experience, hysterectomy rates are 2-4 times higher among Black women compared with White
women. The reasons for this difference remain unclear. Clinical considerations, such as uterine size, only
partially explain the disproportionately higher rate of hysterectomy among Black women. Timely diagnosis and
early treatment represent crucial steps in UF care and may contribute to observed racial disparities in treatment
and outcomes. Differential delays in diagnosis or treatment initiation for Black women with UF compared with
White women could result in longer duration of UF progression and growth, higher rates of care complications,
and fewer treatment options. We know little about the UF care pathways, including the need for urgent services,
like hospitalization, for symptoms. We also do not know to what degree community-level characteristics
contribute to racial disparities in UF care patterns and outcomes. This proposal builds on existing knowledge
about racial disparities in UF treatment patterns (e.g., uterine-sparing vs. hysterectomy) by comparing UF care
pathways among Black and White women living in a variety of neighborhood settings. This proposal will clarify
how care timeliness is associated with differences in treatment patterns and the excess morbidity experienced
by Black women. Our project complements the other projects in the Partnering for Equity: An Academic and
Community Alliance to Eliminate Disparities throughout the Fibroid Experience (PEACE) Center
examining UF etiology (Project 2) and patient experience (Project 3) and will be under the advisement of the
Center’s Community Stakeholder and Advisory Board (CAB). Our experienced team will conduct the proposed
study of care pathways for symptomatic UF among >27K Black and White Michigan Medicaid enrollees and will
leverages data from detailed health records of >13K Black and White individuals in Southeastern Michigan
between 2016 and 2024. The Aims are to 1) compare UF care intervals between Black and White Medicaid
enrollees with symptomatic UF, 2) determine if the relationships between care interval duration and
urgent health service use differ between Black and White individuals and 3) determine if neighborhood
resources affect the relationships between race and care interval duration or urgent health service use.
Impact and significance. Findings from this large, longitudinal analysis of a racially and socioeconomically
diverse group of individuals with UF can assist efforts to target care processes to reduce racial disparities in UF
treatment and health outcomes through clinical care programs, health system design, or health policy. By
achieving our proposed aims, we will identify potentially modifiable care processes and structural factors that
could be targeted by future interventions.